Development of novel nanotherapeutics to overcome therapy resistance using canine brain tumor as a spontaneous model

Title: Development of novel nanotherapeutics to overcome therapy resistance using canine brain tumor
as a spontaneous model
Project Summary/Abstract
High-grade gliomas (HGGs), including glioblastoma (GBM), are uniformly fatal primary brain tumors. Despite
decades of research, there have been almost no regulatory drug approvals for treatment of GBM in the United
States since bevacizumab in 2009. The lack of therapeutic advancement highlights therapeutic resistance of
HGG and the dependency on preclinical rodent models that do not faithfully recapitulate the heterogeneity and
complexity of human tumors. To address these unmet needs, the goal of this application is to develop novel
nanotherapeutics to overcome therapy resistance using companion dogs with HGG as a spontaneous model.
The current standard-of-care therapies for primary or recurrent HGG cause autophagy induction and result in
cell resistance and enhancement of stemness features. Glioma stem-like cells (GSCs) have been linked to tumor
recurrence and drug resistance. Enrichment of GSCs after chemotherapy is associated with more aggressive
tumor rebound. Glioma cells, particularly GSCs, highly rely on elevated autophagy. Therefore, autophagy is a
promising target in HGG to improve treatment and overcome therapy resistance. Aminoquinoline drugs,
chloroquine (CQ) or hydroxychloroquine (HCQ), have been tested in several clinical trials as autophagy inhibitors
and demonstrated their positive effect in improvement of median survival of patients after radiation/temozolomide
treatments. However, CQ/HCQ suffers from limited potency in inhibiting autophagy, adverse effects at
therapeutic dose level, and non-specific delivery profiles. Furthermore, the blood-brain barrier/blood-brain tumor
barrier (BBB/BBTB) poses a unique challenge for successful therapeutic delivery to brain tumors. Recently, we
have developed a series of novel bisaminoquinoline derivatives (BAQD) by pharmacophore hybridization
approach. BAQDs have outstanding autophagy inhibiting- and lysosomal disrupting- capabilities and are 30-50
times more potent than CQ and HCQ. The lead BAQD is undergoing IND submission (#165331) for first-in-
human clinical trials in 2024. We also developed novel BBB/BBTB-traversing and tumor-penetrating
nanoparticles (BTNs) to significantly improve the drug delivery to brain tumors. In this proposal, we plan to 1)
develop a series of BAQD loaded BTNs (BTN@BAQD) and investigate their effect in reversing drug resistance
and cancer stemness in HGGs, 2) evaluate their delivery efficiency and antitumor efficacy in orthotopic glioma
rodent models, and 3) ultimately determine the pharmacokinetics (PK), toxicity, tumor uptake and therapeutic
response of selected BTN@BAQD in dogs with spontaneous HGG. SN-38, a highly potent metabolite of
irinotecan will be co-loaded into BTN@BAQD to kill bulk glioma cells. We anticipate that our BAQD loaded
nanoparticles can efficaciously improve the treatment of brain tumor through effective autophagy inhibition by
potent BAQD and efficient delivery of high concentrations of drugs to gliomas by our unique BTN strategy,
respectively. Our team’s expertise in cGMP nanoparticle production and successful experience in moving a
nanoformulation into clinical trials (NCT05519241) will facilitate the clinical translation of the BTN@BAQD.

Public health relevance
Project Narrative The proposed next generation blood-brain barrier-traversing and brain tumor penetrating nanoplatform addresses autophagy-dependent drug resistance and tumor recurrence and exhibits great potential to be translated into an effective treatment modality that could be easily integrated into the standard of care of high- grade gliomas. Due to the genetic and physiological similarities to humans, dogs with spontaneous high-grade gliomas are an ideal translational model that will accelerate the development of the proposed new therapeutic approaches. The team of experts in neuro-oncology (Dr. Bloch) and veterinary neurology (Dr. Toedebusch) will provide comprehensive expertise to facilitate the clinical development of the proposed novel nano-therapeutics that will ultimately benefit many human and canine patients with brain tumors.